IGF::OT::IGF The development leading to the commercialization of a bioresorbable stents (BRS) for the treatment of coarctation of the aorta (COA) in neonates.

DEVELOPMENT LEADING TO THE COMMERCIALIZATION OF A BIORESORBABLE STENTS (BRS) FOR THE TREATMENT OF COARCTATION OF THE AORTA (COA) IN NEONATES.